Nuclear Receptor Corepressor 1 and 2 and Their Role in Metabolism via Intestinal Actions

PROJECT SUMMARY/ABSTRACT
The nuclear receptor corepressor 1 (NCoR1) and it’s paralog, the nuclear receptor corepressor 2
(NCoR2; also the silencing mediator of retinoic acid and thyroid hormone receptor (SMRT)) are critical proteins
that help maintain metabolic health and normal physiologic function in nearly all tissues where they have been
studied. Despite this, much remains unknown about the molecular mechanisms and targets of NCoR1 and SMRT
and how they act in a tissue-specific fashion to regulate body weight, glucose levels, and insulin sensitivity – key
parts of the pathogenesis of diabetes, obesity, and other metabolic conditions. Although many advances have
been made in the treatment of diabetes and obesity, there remain fundamental gaps in our knowledge about
these diseases. Advancing our understanding of how NCoR1 and SMRT regulate metabolic pathways has the
potential to identify new targets for treating metabolic diseases.
This is a five-year research proposal and career development plan focused on the study of the molecular
mechanisms of NCoR1 and SMRT in metabolic health, specifically via their actions in the intestine. The aim is
to expand our understanding of body weight and glucose regulation by NCoR1 and SMRT, which we hypothesize
is in part by actions on key carbohydrate transporters. The candidate is an Assistant Professor of Medicine in
the Section of Endocrinology, Diabetes, Nutrition, and Weight Management at Boston University’s Chobanian
and Avedisian School of Medicine. The proposed research will be carried out under the mentorship of Dr.
Anthony N. Hollenberg, a leader in the field of NCoR1, SMRT and thyroid hormone action who has trained many
young investigators. An advisory committee of talented and well-established physician-scientists has been
assembled to offer guidance with experimental plans and career development. The School of Medicine has
extensive core facilities, resources, and intellectual expertise so is an ideal training environment for the candidate
to transition to an independent physician-scientist.
This proposal continues upon the preliminary experiments that show the loss of these proteins throughout
the intestine leads to a reduction in body weight and lower glucose levels. More specifically, this study aims to
determine the functional mechanism by which their loss leads to these outcomes (Aim 1), to identify the pathways
regulated and molecular targets of NCoR1 and SMRT in the intestine (Aim 2), and to establish a model of NCoR1
and SMRT knock-out in a human intestinal organoid cell line (Aim 3). These experiments will elucidate the
molecular mechanisms and pathways regulated by NCoR1 and SMRT in mice and begin to translate these
findings in a human model. The results of these studies will further our understanding of the physiologic
underpinnings of body weight and glucose levels and will highlight pathways on which to base future therapies.
We expect these experiments will allow us to improve the care of patients with metabolic diseases, first and
foremost by giving us an understanding of disease mechanisms.

Public health relevance
PROJECT NARRATIVE The prevalence of metabolic diseases, including type 2 diabetes and obesity, continues to rise and represents a public health crisis. Efforts to improve outcomes of these conditions have been hindered by a lack of basic understanding at the cellular level of these processes. The proposed research aims to identify new pathways contributing to body weight and glucose levels with the vision that this information will be harnessed to develop novel treatment options for those suffering from metabolic diseases.